A Digital and Open-Source Amplifier for Oocyte Ion Channel Measurements

Project Summary / Abstract Ion channels and transporters are critical components of the nervous system, and their electrophysiological characterization plays an essential part in understanding many neurological diseases. Voltage clamp techniques characterize ion channel electrical behavior by controlling membrane voltage while measuring membrane current. Cut-Open Vaseline Gap (COVG) is a speciﬁc voltage clamp technique that provides a unique combination of high-speed/low-noise needed to resolve fast protein dynamics and the rare ability to control both intra- and extra- cellular solutions. However, the COVG technique is regarded as challenging in part because the only commercial ampliﬁer is manually operated and requires considerable experience and skill. Further, this commercial ampliﬁer is no longer supported. The COVG user community needs an easy-to-use, high-performance replacement that also makes the technique accessible to more laboratories. In this proposal, we will design, build, and test a new COVG ampliﬁer that leverages modern digital electronics. This proposed digital ampliﬁer will use an innovative approach to automate experiment setup and to continuously adapt setup parameters during the experiment. These approaches will decrease the time required for experiments and maintain optimal feedback as system parameters evolve. The ampliﬁer will have multiple inputs and outputs that are controlled and read digitally. These multiple signals will be used in digital signal processing and control systems algorithms to improve the speed of the ion channel voltage control and allow the experimenter to resolve faster dynamics. The modular ampliﬁer design will create general-use circuit building blocks with digital control systems for feed- back. These components can be leveraged by the electrophysiology community to extend this development to applications beyond COVG. Examples include Two-Electrode Voltage-Clamp (TEVC) and dynamic clamp. A critical contribution of this proposal is the training of undergraduate electrical and computer engineers and neuroscience students, which will be facilitated by an open-source ethos. The design, build, and test of this electrical instrument includes a variety of sub-projects each with a separate focus that augments our under- graduate curricula. These sub-projects will be easily accessible to undergraduate students through hosting in a publicly accessible repository (e.g. using GitHub) following best practices of open-source software. The ampli- ﬁer will be evaluated for repeatability and reproducibility using oocytes by a set of beta-testing labs. Following biological validation, the hardware, software, and ordering information will be publicly available to encourage elec- trophysiology experimenters to contribute improvements and modify the instrument to enable novel experiments. Experimenters may utilize components of this design to develop new electrical instrumentation based on digital feedback for techniques other than COVG.

Public health relevance
Project Narrative The electrophysiological characterization of key neural circuit components of ion channels and transporters re- quires specialized voltage clamp ampliﬁers. We will leverage modern digital electronics and control systems to create a new voltage clamp ampliﬁer instrument that automates experimental setup, provides digital feedback control, and captures low noise data of fast protein dynamics. The entire instrument design will be open-source to maximize the beneﬁt to the scientiﬁc community and to allow experimentalists to modify the instrument to suit novel measurements.